Metabolite regulation of adipocyte differentiation in obesity

ABSTRACT
The triad of obesity, insulin resistance, and type 2 diabetes mellitus (T2DM) affects roughly 33% of U.S. adults
and raises the risk of death from cardiovascular disease. The epidemiological association of obesity with T2DM
is unequivocal, but mechanistic links remain unclear. However, it is clear T2DM is distinctly associated with
defective fat cell (adipocyte) function, particularly energy storage as lipids and secretion of hormones for
systemic insulin sensitivity. We discovered the expression of the enzyme aspartoacylase (ASPA) in white
adipose tissue (WAT) correlates with insulin sensitivity in obese subjects. ASPA governs intracellular acetate
generation and myelin formation in the brain, but its effect in other tissues remains unknown. This
application's overall scientific objective is to unravel how ASPA and acetate contribute to lipid substrates in WAT
using well-established in vitro tools and mouse models of obesity. The central hypothesis is that ASPA-derived
acetate promotes adipocyte differentiation and systemic energy balance. I will test this hypothesis by pursuing
three specific aims: 1) Demonstrate how altered ASPA expression affects lipogenesis in white adipocytes;
2) Define the impact of extracellular acetate on adipogenic competency of precursor cells; 3) Establish the
metabolic effects of ASPA disruption in vivo. Mature adipocytes express high ASPA levels and byproducts of
ASPA activity flow into lipogenesis, nucleotide biosynthesis, and histone modifications. Therefore, ASPA function
likely integrates multiple pathways necessary for adipocytes to overcome nutrient demands in obesity. Lastly,
the mentor and training environment will build research and career development skills to realize my ultimate goal
of becoming an independent scientist.

Public health relevance
PROJECT NARRATIVE Insulin resistance often reflects an inability of white adipose tissue (WAT) to consistently respond to nutrient demands. The enzyme aspartoacylase (ASPA) is involved in lipid synthesis and is highly expressed in white adipose tissue, though its importance outside the brain remains unknown. My preliminary results suggest ASPA plays a prominent role in adipocyte differentiation and lipid storage within white adipose tissue; thus, this research seeks to define the function of ASPA in WAT and understand how its expression contributes to energy balance.